Core--Methods core

The purpose of the Methods Core is to provide expertise in data acquisition, analysis, and management. In addition, members of the Methods Core will provide consultation on statistical methodologies for all projects. Data analysis methods will be provided to meet the needs of each project while ensuring consistency in the methods used across each of the projects. The Methods Core will be responsible for data managed at the Center. Data storage will be centralized on one or more services. Each project will be provided access to the data through the standard access protocols such as DICOM or NFS. The Methods Core will ensure that the methodologies, algorithms, and data management techniques employed at the Center advance with improved in each of these fields. Specific Goals of the Methods Core are to: 1. Provide each project with the image data acquisition parameters required to test the research hypotheses. 2) Assist each investigator with the analysis of the imaging and behavioral and data ensuring statistical rigor and consistency across projects. 3) Maintain an image and behavioral data archive with accurate tracking of subject data and proper archival. 4) Ensure that investigators have access to their imaging and behavioral data. 5) Ensure that the analysis methodologies used at the Center are kept abreast of the changes that develop in the imaging field.